Expanding Minnesota's Rapid Response Team through Outreach, Engagement, and Enhancements

Minnesota RRT Project Summary/Abstract
The Minnesota Department of Agriculture (MDA) Rapid Response Team (RRT) is eligible to
apply for this Cooperative Agreement under Level III of the RRT Maintenance Track. The MDA
RRT has received funding since the program’s inception and is in full conformance with the FDA
Manufactured Food Regulatory Program Standards (MFRPS) and has a 20.88 agreement in
place with FDA. The mission of the MDA is to enhance Minnesotans’ quality of life by ensuring
the integrity of our food supply, the health of our environment, and the strength of our
agricultural economy. The MDA RRT coordinates closely with federal, state, and local agencies
to respond to outbreaks, contamination events, or other incidents which may affect the safety of
the human food or animal feed supply. While the RRT is housed within the MDA, RRT staff work
closely with environmental health staff and epidemiologists at the Minnesota Department of
Health (MDH) who serve as leads and subject matter experts during human illness outbreaks.
Continuation of this funding will allow MDA to continue the efforts and initiatives started during
the last five-year Flexible Funding Model grant cycle. During the next three-year funding period,
the MDA Rapid Response Team will work on a number of objectives and deliverables described
in the Research Strategy including an annual exercise and After-Action Review with non-
traditional partners, continued conformance with Standard 5, contributions to the annual
Midwest Regional RRT Meeting, a Live Animal Market training and procedure development,
industry-focused pesticide drift data analysis, a shopper history impact project, and yearly RRT
trainings focused on specific program areas to build capacity and sustainability.
The MDA RRT will also continue to contribute nationally as a mentor to the WI RRT, a mentor to
the GA RRT Coordinator, a member of the RRT Advisory Committee, and an active contributor
when there are updates to the RRT Manual or CAT data. Members of the MDA RRT will also
continue to participate in a variety of national workgroups and associations including the
Shopper History Outbreak Partnership (SHOP), Partnership for Food Protection (PFP), and the
Association of Food and Drug Officials (AFDO).

Public health relevance
Minnesota RRT Project Narrative Funding provided through this Cooperative Agreement will ensure the continued development of a sustainable Rapid Response Team (RRT) that consists of expanding knowledge through data sharing, training, and exercises; strengthening the link between epidemiology, laboratory, and environmental health components of emergency response; and seeking out projects to enhance response capabilities. During this project period, the MDA RRT will conduct exercises with non- traditional response partners, complete RRT training with three FFSD inspection programs, and share project outcomes related to live animal market outbreaks, pesticide misuse data, and shopper history use impact. Continued funding will allow the MDA RRT to provide valuable input at a national level to the RRT Manual, CAT revisions, response-related procedures, and other national workgroups supporting RRT work.